Activity-Dependent Plasticity in an Associative Hippocampal Circuit: Mechanisms, Synaptic Learning Rules and Involvement in Disease

The dentate gyrus (DG) of the hippocampus plays a key role in memory formation by transforming patterns of
cortical inputs into new patterns of output to the CA3 area. Although the cellular and synaptic basis of this
important transformation remain poorly understood, two excitatory cell types in the DG, granule cells (GC) and
hilar mossy cells (MC), play a major role. MCs mediate an intrinsic, hetero-associative (GC-MC-GC) excitatory
loop, receiving powerful input from a relatively small number of GCs, and providing highly distributed excitatory
output to a large number of GCs. MCs project their associational and commissural axons to the ipsi- and
contralateral inner molecular layer of the DG, where they synapse onto proximal dendrites of GCs. Moreover,
MCs also project their axons along the septotemporal axis of the hippocampus, thereby connecting functionally
diverse areas of this structure. By projecting to most areas of the DG along the septotemporal axis, MCs could
provide important contextual content to the information arising from the cortex. In order to understand how
information is processed in the DG and how dysregulation of this circuit may contribute to disease, a better
knowledge of the hetero-associative GC-MC-GC circuit and its dynamic properties is required. We have
recently reported that MC-GC synapses undergo a novel presynaptic, NMDA-receptor independent form of
long-term potentiation (LTP) that requires postsynaptic brain-derived neurotrophic factor (BDNF)/TrkB and
presynaptic cyclic AMP(cAMP)/PKA signaling. We hypothesize that this novel form of plasticity enhances GC
output at the associative MC-GC recurrent circuit, and may contribute to DG-dependent forms of learning and
brain disease, such as epilepsy. A large number of questions regarding this circuit remain unanswered.
Preliminary data indicates that MC-GC LTP is induced in vivo by experience and epileptic activity, is critically
regulated by endogenous systems (e.g. endocannabinoid and adenosine signaling), and it can be
accompanied by LTP of inhibitory transmission. Here, using a combination of experimental approaches both in
vitro and in vivo, we aim to (1) characterize the synaptic learning rules of MC plasticity, (2) identify the
molecular mechanism underlying MC-GC LTP, (3) determine the properties and mechanism underlying
inhibitory LTP, and (4) determine the functional relevance of MC plasticity in vivo. By identifying the main
properties and mechanisms of activity-dependent plasticity in a crucial recurrent circuit in the DG, our proposed
studies may not only improve our understanding of the precise role of this circuit in DG information processing
and memory encoding, but also assess how dysregulation of this circuit may contribute to brain disease,
including epilepsy, anxiety, schizophrenia and depression.

Public health relevance
Brain functions such as memory and learning critically rely on activity-dependent modifications of the neural circuits involved. The hippocampus, a key brain structure for the formation of new memories, receives information from multiple brain areas and also contains an intrinsic, excitatory recurrent circuit, which has been implicated in learning and epilepsy. A better knowledge of this circuit and its dynamic properties is required in order to understand how information is processed in the hippocampus and how dysregulation of this circuit may contribute to disease.